ESTIMATION OF ORAL CYSTEAMINE BITARTRATE AT STEADY STATE IN CYSTINOSIS

Determine white blood cell cystine and plasma cysteamine levels in patients who have reached their maximum dose of cystagon and who have maintained their dose for at least 6 months. Evaluate the clearance of cystagon over the patients 6 hour dose interval.